Two-way Texting (2wT) to Improve Patient Retention While Reducing the Healthcare Workload in High-Burden Public HIV Clinics in Malawi

In sub-Saharan Africa (SSA), retention of people living with HIV/AIDS (PLHIV) in antiretroviral therapy (ART) is
an increasing challenge. Retention is not stagnant: PLHIV cycle into and out of ART over time. Few mHealth
innovations have been tested or proven effective in real-world, public SSA settings. mHealth innovations that
successfully retain more clients on ART, at lower cost, within large-volume public ART clinics in SSA are urgently
needed. Lighthouse Trust (LT), the largest public provider of ART in Malawi, operates two large clinics in
Lilongwe with the Malawi Ministry of Health (MoH) with a combined 36,000 ART clients. Both clinics employ a
real-time electronic medical records system (EMRS) and implement a resource-intensive client retention
program, Back to Care (B2C). B2C aims to trace clients who miss ART visits by >14 days. B2C demand, coupled
with healthcare worker (HCW) constraints and poor data, results in tracing delays, interrupted treatment, and
lost to follow-up (LTFU). Therefore, LT and the University of Washington's International Training and Education
Center for Health (I-TECH), with support from MoH and Medic, implemented an innovative, proactive, client
retention system using two-way texting (2wT) between new ART clients and HCWs (R21/R33TW011658). 2wT
aims to resolve potential retention issues before they occur and improve data quality (e.g. identifying transfers),
reducing B2C workload. Initial 2wT results from the 468 clients in the parent study found that 86% were alive
six months post ART initiation compared to 76% in standard of care with reminder calls from buddy supporters
(SoC). The probability of being alive and on ART at 6 months was 93.9% (95% CI 89.8-95.1) for 2wT clients
and 83.1% (95% CI 79.3-86.2%) in SoC. Patients in 2wT arm were 64% less likely to drop out compared to SoC
clients (RR 0.36, 95% CI 0.23-0.55). 2wT appears to lower 12-month retention costs over SoC. This proposed
supplement in R33 year 2, will amplify the implementation science (IS) focus and deepen understanding
of for whom, where, how and at what cost can retention be optimized? This supplement aims to: 1) Use
secondary EMRs and 2wT data to describe retention patterns and cycles in care among 2wT and LT's overall
cohort over time and by client characteristic, building mathematical models to guide retention optimization over
a 5-year period; 2) Qualitatively explore diverse LT client perspectives, preferences, and experiences with 2wT
and complementary retention efforts, gaining understanding of differential retention support needs over time;
and 3) Strengthen retention costing analysis to reflect actual cycles of 2wT care engagement, tracing, and
reengagement (visit adherence and retention in ART) over time to advocate for appropriate resources and
inform an optimized, cost-effective retention approach. We engage MoH and other stakeholders in a
participatory approach, presenting preliminary results at 6 months to jointly define 12-month outcomes. At 12-
months, we will deliver 2wT recommendations and a retention improvement package that balances scare
resources, reflects client retention realities, and specifies retention strategy based on patient characteristics.

Public health relevance
In the parent R33 study, we aim to demonstrate that interactive, two-way texting (2WT) can increase antiretroviral therapy (ART) retention in public clinics while providing distinct advantages in terms of data quality, costs, and reduced healthcare worker burden over routine retention efforts. This supplement application requests funds to amplify the implementation science (IS) focus and deepen understanding of for whom, where, how and at what cost can 2wT retention be optimized using mixed quantitative, qualitative, and costing methods. A participatory approach in close partnership with Ministry of Health will deliver a suggested 2wT retention improvement package that reflects real-world cycles of client retention, treatment gaps, and reengagement in care; is tailored to diverse client characteristics; and recommends retention interventions over time on ART.